Molecular mechanisms of translational control in sunitinib-induced vascular dysfunction

PROJECT SUMMARY
The vasculature is lined by endothelial cells (ECs). Emerging studies have revealed remarkable endothelial
heterogeneity across distinct tissues, in part dictated by environmental signals from the tissue microenvironment.
EC homeostasis is also tightly controlled by various transcription factors leading to cell-autonomous changes in
gene expression. Although the field of transcriptome analysis has greatly expanded our understanding of
endothelial biology, the extent to which mRNA translational control contributes to the dynamic regulation of ECs,
especially under stress, remains less characterized. Translational control is a key regulatory mechanism that
controls protein abundance and thereby dictates identity and functions across cell types and tissues. In the
present study, we sought to investigate the molecular mechanisms by which sunitinib, a tyrosine kinase inhibitor
(TKI), induces endothelial dysfunction. Sunitinib, a multireceptor TKI, is used as the first-line therapy for solid
tumors such as metastatic renal cell carcinoma. Despite its effectiveness, a considerable number of patients
receiving sunitinib suffer from cardiac and vascular toxic effects. While mechanisms of cardiomyocyte toxicity
have been identified, much less is known about the effects of sunitinib on vascular dysfunction. Thus, a better
understanding of sunitinib-induced vascular toxicity and its underlying mechanisms is critical to mitigate its risk.
As a convergent mechanism downstream of most oncogenic signals, translational rewiring is known to play a
key role in promoting cancer onset and progression. Whether such a regulatory program functions in the context
of cardio-oncology remains largely unknown. Our preliminary data suggest that translation is dysregulated in
sunitinib-treated ECs, leading to translational inhibition of SND1 (Staphylococcal nuclease domain-containing
protein 1), a gene with unknown function in ECs. We established SND1 as a potential novel regulator of
endothelial health, in part due to its cooperation with UBE2N in regulating the DNA damage response signaling
pathway upon sunitinib exposure. Using in silico repurposing of FDA-approved drugs followed by in vitro testing,
ramipril, an angiotensin-converting enzyme inhibitor, mitigates sunitinib-induced vascular damage. Therefore, in
Aim 1 of the proposed studies, our goal is to define the molecular roadmap by which sunitinib translationally
regulates SND1. In Aim 2 of the proposed studies, we aim to dissect the role of SND1 as an important mediator
of endothelial tolerance against sunitinib through its interplay with UBE2N in regulating DNA damage repair. In
Aim 3, we will validate the cardioprotective effects of ramipril in vivo and confirm that it will not interfere with the
effectiveness of sunitinib against tumor growth. Completion of the proposed studies will produce critical insights
into the role of translational control in sunitinib-induced vascular dysfunction and will fundamentally advance our
understanding of the interaction between translation and endothelial homeostasis in general.

Public health relevance
PROJECT NARRATIVE With a concomitant increasing number of cancer survivors and aging population, potential cardiovascular toxic and vascular toxic effects of anti-cancer therapies are on the rise and require immediate attention to prevent the reduction in quality of life. While transcriptional regulation has been extensively studied, translational regulation has not been well defined in cancer drug-induced toxicities. Understanding the mechanisms of translational regulation of vascular cells upon exposure to cancer drugs could provide crucial information for the development of novel approaches to prevent off-target toxicities.